Mechanisms of diet modulating experience-dependent amphetamine preference

ABSTRACT
Substance use disorder (SUD) is a huge public health problem, with last year being a historical record of drug
overdose deaths in the US, with psychostimulants being the cause of a third of those deaths. Years of addiction
research indicate that both genetic and environmental factors influence SUD development. However, as of today
there are no FDA-approved drugs to treat psychostimulant use disorder. Therefore, new approaches are needed.
Recent studies demonstrate that diet influences mental health, including SUD behaviors: diet influences alcohol
drinking and recovery from SUD among others. Despite the evidence linking diet with SUD, mechanistic insight
into how diet and the gut affect SUD development is missing. My proposal aims to elucidate the molecules and
mechanisms of gut-brain communication that modulate dopaminergic neurons and SUD-related behavior by
taking advantage of the genetic tools, fast generation time and high-throughput economy of scale of Drosophila.
To that end, I have developed a robust, quantitative assay that shows flies develop experience-dependent
amphetamine preference. I propose to identify gut to brain signaling pathways as well as dietary components
that alter dopaminergic signaling and amphetamine preference. This proposal leverages my previous knowledge
in Drosophila behavior and will provide training in SUD-related behaviors. Carrying out the career plan outlined
will enable me to achieve my long-term career goal: to become an independent investigator with a research
program focused on the role of diet as a risk factor and possible treatment for SUD.

Public health relevance
NARRATIVE Psychostimulant use disorder accounts for a third of overdose deaths, however, currently there is no FDA- approved pharmacotherapy to treat it. Recent evidence suggests a role for diet and gut signaling in modulating the dopaminergic reward signaling and SUD behavior. I propose to use a recently developed amphetamine preference assay in Drosophila to identify the environmental factors, like dietary components, as well as signaling pathways that modulate this SUD-related behavior.